PRODUCTION OF AMMONIUM TETRATHIOMOLIBDATE (ATTM) CAPSULES FOR USE IN CLINICAL TRIALS

PRODUCTION OF AN ENGINEERING BATCH, CGMP BATCH, DELIVERY, AND SHELF-LIFE STUDY OF AMMONIUM TETRATHIOMOLIBDATE (ATTM) CAPSULES FOR USE IN CLINICAL TRIALS